Implementation Research Institute for Mental Health Services IRI-MHS

Abstract
In response to PAR-20-080, NIMH Mentoring Networks for Mental Health Research Education, this application
seeks five years of support to respond to training demand, continue scientific leadership to the field, and
empower a new generation of leaders in implementation science for mental health services research. This
network will extend in creative new ways the Implementation Research Institute (IRI, NIMH R25 funding 2009-
2015, 2016-2019), which has successfully trained 87 new mental health implementation researchers.
Implementation science is critical for mental health where most Americans with mental disorder receive sub-
optimal care due in large part to challenges in the implementation, sustainability, and scale-up of evidence-
treatments. Training demand far outweighs supply but only a handful of programs train implementation
researchers and only the IRI in mental health. Therefore we seek a five-year renewal of IRI to pursue three
aims: (1) to continue a vibrant mentoring network of Faculty and Fellows who will advance the science and
lead the workforce in mental health implementation research; (2) to accelerate training benefits and enhance
IRI sustainment by elevating new mentoring leadership in implementation science, and (3) to evaluate training
outcomes. We will achieve aim 1 by (a) conducting an innovative, continually renewed annual summer
institute; (b) fostering networked collaboration and mentoring from faculty to fellow and peer to peer among IRI
fellows; (c) supporting fellows’ travel to externally funded implementation research sites where they will learn
from NIH Principal Investigators, thereby expanding their networks; and (d) equipping IRI fellows, via the
Translational Science Benefit Model (TSBM), to map pathways for the public health impact of the MHSR
implementation science in response to aim four of NIMH’s strategic plan. We will achieve aim 2 by using
evidence-based mentoring and leadership development strategies to train an Associate Director designee and
new core faculty designees, pairing them with seasoned core faculty and advancing them to mentoring
leadership positions in implementation science. We will achieve aim 3 by using evaluation methods that
include TSBM case studies, bibliometrics, social network analysis, and competency assessment to evaluate
outcomes that include mentoring effectiveness, collaboration, translational benefits, and implementation
science to scholarly products.

Public health relevance
Project Narrative The IRI uniquely trains for mental health implementation science, a field essential to attaining objectives in NIMH’s Strategic Plan. Training new IRI Core Faculty members will boost the field’s leadership capacity. Evaluation products will demonstrate translational benefits of implementation science. Fellows’ research will accelerate innovation in implementation science and inform sustainable improvements to mental health care – thereby reducing the burden of mental illness for countless individuals and families.